Engineering human-derived programmable RNA effectors to retune gene expression

Project Summary Genetic deletion (haploinsufficiency) or duplication events are often associated with a variety
of diseases, including: cancers, cardiovascular and metabolic disease, and neuropathies. Because many genes
are sensitive to both over- and under-expression, with imbalances in gene product in either direction leading to
disease, tight regulatory control is a therapeutic necessity. RNA-targeting technologies, however, provide a
mechanism to appropriately and reversibly modulate gene expression at the transcript level, resulting in tunable,
cell-specific remediation of disease-causing shifts in gene dosage. Our recently developed CRISPR- Cas-
inspired RNA targeting system (CIRTS), integrates small, human-derived proteins and guide RNA into an easily
programmed and packaged technology for tunable gene expression manipulation at the transcript level.
Notably, CIRTS imparts a major clinical advantage over that of functionally-related, but bacteria-derived
CRISPR/Cas systems: minimized immunogenic risk stemming from the use of human protein parts. This
proposal seeks to use protein engineering and cell-based screens to create highly efficient, optimized CIRTS-
based technologies – both for gene activation and deactivation – and assess their generality across a panel of
disease-relevant targets, and to test the potential of the technology in vivo. Initial screening will focus on the
gene PMP22, an exemplar gene for which both over- and under-activation result in distinct, but related, genetic
disorders. This provides a fertile testbed for optimization of both CIRTS degraders (Aim 1) and activators (Aim
2). In Aim 1, the human proteome will be mined to identify and characterize functional domains that can be
integrated into CIRTS to programmably degrade PMP22 RNA. How target RNA landing sites correlate with the
functional outcomes of each successful design, as well as generality against another target, SNCA, will be
simultaneously pursued. Aim 2 of the proposal focuses on developing CIRTS activators, mining the human
proteome for novel functional domains and using novel reporter systems to efficiently screen and characterize
them, and finally, assessing lead designs in two other target genes, SCN1a (brain) and JAG1 (liver). Aim 3 will
assess selectivity and specificity constraints of the system, and the generality of the CIRTS technology across a
range of biological contexts. Here, lead CIRTS architectures will be benchmarked against state-of-the-art
Cas13-based systems, comparing immunogenicity in vivo and testing the efficacy of CIRTS-based regulatory
systems in “real world” contexts, namely mouse models of PMP22-based gene dosing disorders. Critically, data
from all three aims feed off of and inform one another, resulting in a tripartite design-build-test optimization
cycle. Completion of this project will generate a multi-modal, programmable CIRTS toolkit for the manipulation
of gene expression at the RNA level. In addition to providing proof-of-principle validation of this system’s
potential in one exemplar clinical application, this work will also produce a unique suite RNA-targeting effectors
with broad utility across a wide variety of biomedical research and synthetic biology fields.

Public health relevance
Project Narrative RNA-targeting gene therapies that precise tune gene expression at the transcript level can address the shortfalls and challenges of current gene therapies, but the large size and microbially-derived nature of existing programmable RNA-targeting systems preclude broad clinical utility. Constructed from human protein parts, CIRTS (CRISPR/Cas-inspired RNA targeting system) offers a therapeutically actionable solution to these hurdles. Here, we will use biochemical engineering approaches to generate highly efficient RNA-targeting CIRTS activators and degraders and prioritize those with optimized performance parameters using a combination of disease-relevant target gene assays and in vivo immunogenicity studies.